EFFICACY AND TOLERABILITY COMPARISON OF PROSCAR AND PLACEBO IN BPH

This protocol is designed to determine whether therapy with finasteride provides clinical improvement in patients with symptomatic BPH compared to placebo; to evaluate the tolerance of these patients to the drug; and to evaluate the effect of the drug on the 5-alpha-reductase enzymes, assessed by serum DHT.